A Fail Safe, High Output Failing Fontan Pump

Project Summary/Abstract
This proposal addresses NHLBI Topic of Special Interest HLS17-15, Development of mechanical circulatory
support devices for individuals with congenital heart disease and single ventricle physiology after Fontan
surgical palliation. The design was specifically stimulated by the requirements and design suggestions
outlined to Perfusion Solutions, Inc. (PSI) by pediatric and congenital surgeon Dr. Pranava Sinha. The
surgical treatment and management has dramatically advanced since the early days of development of
surgical treatment of single ventricle heart disease. Patients now routinely survive into their teen and early
adult years. However, significant morbidities develop, ranging from minimal exercise capability through
terminal heart, liver and kidney pathologies. These are a product of diastolic heart dysfunction, and are not
universally relieved with systemic assistance. There is a need for a long term cavopulmonary assist system
which can bridge patients over the often very long wait for a donor heart or potentially serve as a destination
therapy. A suitable device will provide flows and pressures for the superior and inferior vena cavae (defined as
flows of nominally 3.0-6.0 lpm, pressure rises normally between 1 and 15 mmHg but possibly higher with
hypertension, blood compatibility in the venous circulation, and have minimal resistance to forward flow should
pump rotation be interrupted. The PSI approach incorporates a slow, large diameter axial flow impeller to meet
these hydraulic requirements. The rotor contains the impeller and motor rotor; a motor stator in the pump
housing provides rotation. The rotor is supported by a very special blood lubricated bearing design that
produces a thick yet stable film and provides more wash flow clearance. During the phase I research, the
hydraulic design will be refined, and other components designed. Satisfaction of the success criteria will be
shown, specifically, obtaining the defined hydraulic performance, minimal hemolysis, low static pressure drop,
and an indication of long term durability. During Phase II, clinical prototypes will be built and evaluated in
depth, including in vivo studies. PSI was incorporated in 2008 to commercialize the technology developed by
Principal investigator Dr. William Smith during his career at the Cleveland Clinic; in 2012, after 30 Cleveland
Clinic years, he retired and joined PSI full time. PSI has partnered for several years with Dr. Pranava Sinha to
use PSI’s PediPump as part of Dr. Sinha’s Fontan support research program. Dr. Sinha will continue as the
medical design consultant for this new program, and lead the future in vivo program.

Public health relevance
Narrative Surgical treatment of congenital single ventricle heart disease has advanced very significantly, leading to large numbers of infants now surviving into their teen and early adult years and experiencing significant medical issues as a result of the long-term absence of a right side ventricle. This project will demonstrate an effective, long term implantable pump for use in the venous system to address the disabilities and deaths that result from the long-term failure of single ventricle palliation (“Fontan”) procedures.